Mid-Atlantic Microbial Pathogenesis Meeting 2022

ABSTRACT
The 11th Mid-Atlantic Microbial Pathogenesis Meeting (MAMPM) will be held February 13-15, 2022 at
Wintergreen Resort and Conference Center near Charlottesville, Virginia. The purpose of the MAMPM is to
foster communication and collaboration among microbial pathogenesis researchers in the Mid-Atlantic (NC,
VA, MD, DC, WV, and DE, though researchers from 12 states are now attending). Numerous FDA-funded
investigators studying the virulence mechanisms of pathogens of importance to human health are in this
geographic region and have participated in multiple MAMPMs. One of MAMPM’s key goals is to provide
students, postdoctoral fellows, and junior faculty with the opportunity to present their work to a knowledgeable
audience, focused on this discipline, in a collegial yet scientifically rigorous environment. Conference
evaluations consistently MAMPM is a formative experience for young scientists’ professional development and
remains one of the most appealing, and positively evaluated, aspects of this conference. All ten previous
meetings have been held at Wintergreen Resort Conference Center, which features a central location,
excellent facilities, and a professional conference staff. At our last meeting (2019), we achieved maximum
registration (201 attendees) for the first time.
MAMPM 2022 is arranged by the Organizing Committee, comprised of the current, future, and past two
conference chairs. The vast majority of the presenters are graduate students, postdoctoral fellows, and junior
faculty with four internationally renowned keynote speakers introduce each session. Drs. Tod Merkel (FDA
staff scientist), Virginia Miller (UNC), Leigh Knodler (WSU), and Martin Wiedmann (Cornell) are the MAMPM
2022 keynote speakers. In addition, two highly attended and interactive poster sessions will be provided to
allow the opportunity for all participants to present and discuss their work face-to-face. MAMPM 2022 will be
publicized through advertisements in professional publications, social media posts, and direct mailings
(physical and email) to relevant departments at academic institutions, government and private laboratories
within the region and to members of the local American Society for Microbiology branches that serve this
region. A dedicated website (http://mampm.org/) publicizes the meeting and provides the necessary
information and forms required for registration. MAMPM also strongly supports diversity in sex/gender,
race/ethnicity, age, and disability status. Drs. Ashley Haines and Carleitta Paige-Anderson will serve as
Diversity Ambassadors to enhance participation from underrepresented groups. MAMPM 2022 will feature the
MAMPM Advancing Diversity Initiative, with panels of diverse composition to discuss career transitions.
Finally, research presented at MAMPM is highly relevant to FDA's mission, particularly in the development
of novel vaccines, diagnostic and treatment platforms for the human diseases, and protection the public
against the threats of emerging infectious diseases.

Public health relevance
PROJECT NARRATIVE The purpose of the 11th Mid-Atlantic Microbial Pathogenesis Meeting (MAMPM) in February 13-15, 2022 is to foster communication and collaboration between scientists engaged in research focused on disease- causing microbes in this geographic region. The goal of the organizers is to assemble a high-quality scientific program to attract outstanding principal investigators along with their undergraduates, laboratory technicians, graduate students, post-doctoral fellows, and junior faculty. Many of the meeting’s anticipated participants are in the Mid-Atlantic region and direct research programs studying the pathogenesis of bacterial diseases. This meeting will provide an opportunity for junior scientists to present their work to a knowledgeable audience in a supportive and collegial environment. MAMPM 2022 will promote a diverse attendee and speaker portfolio by advertising the conference to institutions with historically underrepresented populations, prioritizing diversity in the selection of speakers, and hosting a panel discussion on career transition points to highlight and emphasize the diversity of the field and is an exceptional opportunity for junior scientists to enhance their scientific and professional development.